Animal and Phenotyping Core

ANIMAL AND PHENOTYPING CORE
PROJECT SUMMARY
The Jackson Laboratory Nathan Shock Center (JAX NSC) provides diverse animal resources to enhance
research in the genetics of aging. The overall goal of the Animal and Phenotyping Core is to increase the diversity
of mouse resources available for aging research. The JAX NSC remains the preeminent aging research center
for the development and dissemination of aging mouse models and resources. These resources include 32
common inbred strains for which the JAX NSC freely provides comprehensive lifespan and healthspan data via
the interactive Mouse Phenome Database (MPD). In the current funding period, JAX investigators established
models to study the genetics of aging using highly diverse strains, including Collaborative Cross (CC) inbred
strains and Diversity Outbred (DO) mice. In addition to animal resources, a robust phenotyping pipeline ideally
suited for large-scale, non-invasive testing of aging mice was developed. The Animal and Phenotyping Core will
continue to generate valuable, high-demand animals and phenotyping resources for the aging community and
distribute these resources effectively to ensure their widespread use. The Core will also promote the overarching
goals of the NIA Nathan Shock Center Program through extensive interactions with all other JAX NSC cores,
with other NSCs and the NSC Coordinating Center (NSCCC), and with the aging community at large. The
Specific Aims of the Animal and Phenotyping Core are to: Aim 1. Provide unique animal resources to support
aging research. Specifically, in Aim 1A, aging colonies of DO, CC, and C57BL/6J mice will be continuously
maintained “on the shelf” and available for Pilot Awards. In Aim 1B, in conjunction with the Data and Statistical
Core, the lifespan, extensive healthspan phenotyping, and QTL analyses of the dietary intervention study
initiated in the prior funding period will be completed.Aim 2. Enable characterization of animal resources by
providing robust and novel phenotyping assays relevant to human lifespan and healthspan. Affordable,
novel, targeted phenotyping, and tissue and blood samples will be provided to researchers in the aging field to
facilitate a comprehensive characterization of aged mice. Aim 3. Implement a large-scale study on the impact
of genetic diversity on senescence and the effect of senolytics in DO mice and couple phenotypic
responses to the underlying genetics. Senescence and the effect of senolytics have only been studied in
C57BL/6J mice. Male and female DO control mice and mice treated with senolytic ABT263 will be extensively
phenotyped in order to couple senescence and senolytic treatment in various tissues and phenotypic responses
at 24 months of age to the underlying genetics. Aim 4. Coordinate with the Data and Statistical Core to
analyze data and streamline dissemination efforts to the aging community via the JAX NSC website and
the MPD. The Animal and Phenotyping Core will support aging research by continuing to generate and distribute
valuable, high-demand mouse genetic and phenotyping resources for the aging research community.